The Role of Extracellular Matrix Dysregulation in Heterotopic Ossification

PROJECT SUMMARY
Heterotopic ossification (HO) is the pathologic formation of ectopic bone in extra-skeletal tissues.
Approximately 20% of patients who suffer some type of musculoskeletal injury develop HO. These injuries can
be traumatic in nature or controlled tissue damage that occurs as a part of routine orthopaedic surgeries like
joint replacement surgery or surgical amputations. The risk of HO disproportionately affects the Veteran
population compared to civilians, especially due to higher risk of experiencing traumatic blast, brain, or spinal
cord injury. Indeed, 64% of military blast injuries from the recent conflicts and Iraq and Afghanistan have
resulted in HO. The presence of HO is associated with chronic pain, chronic infection, ulceration, impaired
wound healing, and other related health complications. These complications from HO often preclude regaining
mobility and function in the injured limb and substantially limit the use of prosthetics, impeding Veteran
independence and return to duty or integration into civilian life. These difficulties can lead to opioid addiction,
depression, and suicide, which are all major concerns to overall Veteran health. Current treatment options are
limited due to the lack of understanding of the molecular mechanisms that drive ectopic bone formation during
soft tissue healing following damage. Thus, the proposed work seeks to elucidate the mechanisms driving
bone formation in HO in order to identify new, targeted therapeutic approaches for preventing and treating
ectopic bone formation. The extracellular matrix (ECM) plays an essential role in regulating many biological
processes including tissue repair and maintenance. While upregulated inflammation due to injury is known to
significantly increase ECM synthesis, mechanisms linking aberrant ECM deposition to ectopic bone formation
remain largely unexplored. We have carried out preliminary experiments in mouse models that consistently
form ectopic bone that is histologically similar to HO in patients. Importantly, the soft tissue changes that are
observed in these mice leading up to HO, particularly the aberrant and progressive accumulation of ECM
molecules like collagens (COLs) and glycosaminoglycans (GAGs), closely recapitulate the changes observed
in patients. Therefore, we hypothesize that abnormal overproduction of COL I and chondroitin sulfate (CS)
GAGs creates an ECM environment capable of activating aberrant osteogenic signals in soft tissue in HO. The
overall objective of this proposal is to elucidate the role of COL I and CS GAG accumulation in ectopic
bone formation in order to identify potential therapeutic strategies and diagnostic markers using
mouse models of HO. In Aim 1, we will determine the critical concentration and chemical composition of COL
I and CS GAGs in the ECM that is able to establish a microenvironmental niche conducive for osteogenic
differentiation and verify the concomitant upregulation of associated bone formation markers. In Aim 2, we will
establish the inhibition of COL I and CS GAG accumulation as potential treatment strategies for inhibiting HO.
In Aim 3, we will identify circulating biomarkers that may predict predisposition to HO and validate our findings
from mouse model studies in deidentified human patient data through biorepository analyses to establish
clinical relevance. The completion of these studies will establish direct links between excessive ECM
accumulation and activation of bone formation in HO, paving the way for the development of new therapeutic
strategies that can prevent ectopic bone growth by targeting mechanisms of ECM production. Furthermore,
this work will provide critical, fundamental insights to our overall understanding of the role of ECM production in
tissue repair following trauma, which will inform other important studies in fibrosis and wound healing to
improve Veteran health.

Public health relevance
PROJECT NARRATIVE Heterotopic ossification (HO) is the formation of ectopic bone in extra-skeletal tissues due to aberrant soft tissue healing following musculoskeletal damage. Musculoskeletal injuries range widely, from trauma incurred during combat operations to controlled tissue damage during orthopaedic surgeries. Complications from HO include chronic pain, chronic infection, and impaired wound healing, leading to loss of mobility and inhibiting prosthetics use, thus impeding Veteran independence and return to normalcy. These difficulties can lead to comorbidities like opioid addiction and depression that can lead to overdose or suicide, which are all major issues in overall Veteran health. Current treatment options for HO are limited due to the lack of understanding of the molecular mechanisms that drive ectopic bone formation. In this proposal, we will elucidate the links between abnormal extracellular matrix deposition, aberrant osteogenic signaling, and ectopic bone formation in order to identify new treatment strategies to prevent HO formation in our Veterans.